Medical Scientist Training Program

Project Summary / Abstract
This application will support and renew the Medical Scientist Training Program (MSTP) at Stanford University
School of Medicine. In over 50 years of continuous NIH funding, over 350 trainees have graduated from this
program, many of whom have become leaders in their fields of academic medicine and biomedical research.
Our program provides a superb environment and unique advantages for fulfilling our mission “to train a
diverse cohort of pioneering physician scientist (PS) leaders dedicated to a lifetime of biomedical discovery that
improves human health through innovation.” Dual degree pre-doctoral training in the Stanford MSTP has durably
produced successful outcomes in our trainees, based on several metrics used to compare MD/PhD programs
nationally, including low attrition and time to degree conferral, publication record, and high retention of
graduates in biomedical research careers. This proposal describes important changes in the Stanford
MSTP. Program enhancements include a significantly increased level of institutional support, reflected in
increased staffing and faculty effort to direct the MSTP; increased financial support for student training by
the School of Medicine; integrated training in rigorous, reproducible, responsible and safe research conduct
throughout the curriculum; improved mentoring and monitoring mechanisms for students throughout their
training; enhanced career development training and physician scientist community building; new physician
scientist training tracks for MD-only students and recruitment for internal admission to the MSTP; enhanced
integration of MD-only trainees in MSTP activities; and substantial new initiatives to ensure diversity, equity
and inclusion at all levels of the Program. Together, the increased institutional support, increased effort
by School of Medicine faculty and leadership, dedicated program enhancements, and integration of clinical
and graduate training have changed, expanded and improved the Stanford MSTP. Support through this
proposal, heavily leveraged with School of Medicine and University resources, will support continuing
innovation in training physician scientists at Stanford.

Public health relevance
Project Narrative Continued improvement in human health depends on the translation of fundamental knowledge to clinical settings, and the integration of approaches from several different disciplines. The Stanford MSTP embraces and promotes these goals, training physician scientists to be academic leaders for future advances in biomedical research.